mGluR5 and Phase State Dependent Synaptic Loss in Alzheimer's Disease

SUMMARY
Alzheimer’s disease (AD) afflicts 5.8 million in the USA, but there remains no disease-modifying therapy. Critical
for progression from pre-symptomatic to mild cognitive impairment (MCI) to dementia is the loss of synapses in
relevant brain regions. We seek to define the molecular basis of this synapse loss. In the previous cycle, we
demonstrated an essential role for aberrant metabotropic glutamate receptor 5 (mGluR5) activation in synapse
dysfunction, synaptic loss and memory deficits using cellular assays, brain slices and transgenic mice. Our
Preliminary studies here demonstrate that synapse loss is mGluR5-dependent in gene knock-in as well as
transgenic models, and that it can be tracked by longitudinal PET imaging. We have discovered a sub-nanomolar
potent and orally available mGluR5 silent allosteric modulator (SAM, BMS-984923) that blocks this AD process,
while preserving physiological Glu signaling.
We now aim to address two key issues regarding this clinically targeted AD synapse loss pathway. Single cell
transcriptomic profiling will be utilized to understand how synaptic mGluR5 modulation interacts with diverse
molecular pathways and glial cells in AD. Single particle cryo-electron microscope studies will be employed to
understand the basis for differential mGluR5 regulation by Aßo/PrPC vs Glu, and for SAM action. Hypotheses
generated from the transcriptomic and protein studies will be tested in human iPSC-derived neurons and in
mouse gene knock-in models. To maximize relevance, signaling will be triggered by Aßo purified from human
AD brain.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) afflicts 5.8 million in the USA, but there remains no disease-modifying therapy. Critical for symptom progression is the loss of synapses in the brain. We seek to define the molecular basis of this synapse loss, focusing on the role of metabotropic glutamate receptor 5 (mGluR5) activation. In AD mice rescued from synapse loss by a mGluR5 targeting compound, we will profile the expression of genes in hundreds of thousands of brain cells to understand the complex interactions underlying this improvement. Changes in the shape of mGluR5 protein caused by AD will be studied by cryo electron microscopy to define the initiating molecular steps in AD.